Administrative Core

Centralized administration is critical for efficient program management, coordination, and execution. Core A
(Administrative Core) will provide all the logistic, scientific, managerial, and financial support to facilitate
and to coordinate the studies described in this P01 program. Core A will ensure that all the Projects and
Cores function optimally and adhere to the timelines and milestones described in this proposal. Core A will
organize conference calls every two weeks and regular in-person meetings, maintain regulatory approvals,
provide fiscal and logistic oversight, manage subcontracts, and coordinate meetings with the Scientific Advisory
Board (SAB) and NIAID Program Officials to support this P01 program. This detailed administration and
management structure will ensure that all the studies remain focused on the overall objective to define
mechanisms of therapeutic efficacy of bNAbs and vaccines for HIV-1. To accomplish these goals, we propose
the following four Specific Aims:
Aim 1. To coordinate communications, interactions, and operations among investigators, Projects, and Cores to
facilitate the overall progress and goals of this P01 program
Aim 2. To ensure and to maintain regulatory compliance
Aim 3. To provide detailed financial oversight and management
Aim 4. To coordinate meetings with the SAB and NIAID Program Officials